LIDOFLAZINE IN PATIENTS WITH HCM REFACTORY TO STANDARD MEDICAL THERAPY

Many patients with hypertrophic cardiomyopathy have severe symptoms in spite of medical therapy with beta adrenergic blocking agents and/or calcium channel blocking agents. Recently we have been investigating the use of amiodarone, a benzofuran derivative with potent hemodynamic and antiarrhythmic properties in this same subgroup of patients and have noted an improvement in cardiac symptoms and an increase in exercise capacity. However, there remains a subgroup of patients who are intolerant of amiodarone or who do not improve on amiodarone and continue to have marked symptomatology. In response to a compelling clinical need in this subgroup of refractory patients, we felt it appropriate to explore other potential pharmacologic modalities. We have hypothesized that the functional and structural abnormalities in HCM are related to a primary membrane disorder leading to increased cytosolic calcium levels as a result of altered calcium fluxes involving both the myocardium and the vascular smooth muscle of the small intramural coronary arteries. Lidoflazine has been shown to be a potent calcium entry blocker, and has a cellular protective effect against calcium overload in vascular smooth muscle and cardiac muscle during ischemia, preventing ischemic contraction and myonecrosis. These properties of the drug afford an ideal mechanism for testing the above hypotheses, as well as offering a potentially important therapeutic alternative. The study will consist of 3 phases. The first phase to assess the clinical efficacy of the drug; the second to characterize the hemodynamic/metabolic correlates of the drug that may determine its efficacy; and the third to compare in a double blind fashion lidoflazine versus standard therapy. We have enrolled thus far 3 patients in phase I, two of whom have had symptomatic and exercise improvements.